Administrative Diversity Supplement- Novel Nano-Vaccine Technology for Inducing Immunity Against Gliomas

Gliomas are highly aggressive brain tumors and complete tumor resection is not achievable as residual tumor
cells routinely infiltrate the surrounding functional brain tissue and are protected by the blood brain barrier (BBB).
The BBB presents a significant obstacle for effective delivery of therapeutic agents to the central nervous system.
The BBB forms a highly selective semipermeable border that prevents solutes in the circulating blood from
crossing into the intracranial environment. Thus, there is an urgent need for new approaches for drug delivery
through the BBB to gliomas. To address these major unmet medical needs, here we propose to develop new
nanoparticles for delivering STING agonist to gliomas. We will develop nanoparticles that can be tuned with
different targeting moieties and effectively delivered to gliomas; elicit anti-tumor immune response by converting
the “cold” glioma tumors to “hot” tumors; eradicate established gliomas; and generate sustained anti-gliomas
immunity. This Supplement application focuses on applying the knowledge gained from the parent R01 grant to
target STING agonists to gliomas and achieve anti-tumor immunity against gliomas. Therefore, this represents
a new and complementary research component that directly relates to original goals of the grant and broadens
its translational potential and application.

Public health relevance
Narrative The proposed research is relevant to public health because these studies will improve our understanding of the biology-materials interfaces and may lead to new design principles for biomaterials engineered to elicit robust levels of immune responses, thereby addressing current technical limitations in cancer immunotherapy.